Cerebral Protein Synthesis as a Measure of Degenerative Changes in a Transgenic Rat Model of Alzheimer's Disease

During the 2016 funding period, we carried out studies to measure rCPS with the autoradiographic L-1-C-14leucine method in cohorts of WT and TgF344-AD at six, 14, and 18 months of age. In these animals we also measured activity by means of open field behavior, memory by means of the T-maze, olfaction by means of the buried food task, and sleep behavior. In a separate cohort of animals studied longitudinally we measured rCPS with the L-1-C-11leucine PET method. We have completed the behavioral testing and we are in the process of analyzing the results of the rCPS experiments.